Microscopy and Histology Core Module

Microscopy and Histology Core Module – Project Summary
The objective of the Vision Research Core is to enhance the productivity and efficiency of the research
programs of the UW vision scientists, with special priority given to investigators holding NEI R01 grants, and to
promote collaborations among investigators. The Microscopy and Histology Core Module achieves these
objectives by
(i) Providing access to state of the art confocal and electron microscopes, including serial block facing
scanning electron microscopes
(ii) Providing dedicated technical assistance in the use of specialized confocal and electron microscopes
(iii) Providing assistance and training in the preparation of tissue for microscopy
(iv) Providing assistance and training in acquisition and analysis of images from core microscopes
(v) Maintaining module equipment in good working order through service/maintenance contracts and
support of biomedical engineer with expertise in the maintenance and repair of core equipment and
computers